Therapeutic targeting of RTK protein granules in cancer

Project Summary Abstract
Candidate: Asmin Tulpule, MD, PhD, is a pediatric oncologist and physician-scientist whose long-term goal is
to lead an independent laboratory-based research program studying the basic biology and therapeutic
targeting of fusion oncoproteins in cancer. His recent first-author paper in Cell, as well as contributing
authorship on publications in Nature Medicine, Nature Genetics, Cell Reports and first-author papers from his
graduate work in Cell Stem Cell and Blood, demonstrate his potential as a cancer researcher. This K08
application is crucial for his ongoing career development by providing him with key mentorship and training in
1) Mouse modeling of human cancer and pre-clinical drug testing, 2) Microscopy techniques to study
Biomolecular Condensates, and 3) Training in RTK and RAS/RAF biology.
Research: Resistance to standard of care tyrosine kinase inhibitor (TKI) therapy is inevitable for the majority of
patients with RTK fusion-driven lung and other advanced cancers and remains the major cause of mortality.
Dr. Tulpule recently found that multiple RTK fusion oncoproteins self-assemble into membraneless cytoplasmic
RTK protein granules that locally coordinate RAS activation and are critical for oncogenesis. The goal of this
proposal is to develop mechanistically informed therapeutics that target the unique oncogenic signaling
properties of this cancer-specific biomolecular condensate. The following specific aims are proposed: 1) To
test SHP2 inhibitors in xenograft models as a new RTK protein granule-directed therapeutic strategy, and 2) To
determine how membraneless RTK protein granules activate RAF kinases.
Mentorship and Training: Dr. Tulpule’s training will be accomplished through direct teaching of laboratory
techniques, formal coursework, academic conferences, and frequent meetings with his Advisory Committee.
Asmin's primary mentor is Trever Bivona, MD, PhD, a thoracic oncologist with expertise in molecularly targeted
therapies and RAS biology. Dr. Bivona has mentored four post-doctoral fellows to independence within the
past five years and has extensive research support from the NIH (4 NCI-funded R01’s). Dr. Tulpule has
assembled a tremendous team of physician-scientists for his Advisory Committee including co-mentor
Alejandro Sweet-Cordero, MD (pediatric oncologist and expert in xenograft modeling), Bo Huang, PhD (expert
in high-resolution imaging techniques), Kevin Shannon, MD (expert in RAS biology and mouse models), and
William Weiss, MD, PhD (expert in cancer signaling). This Advisory committee has a significant track-record of
mentoring trainees to independence and will provide the necessary scientific and mentoring support.
Environment. Dr. Tulpule's training and research will occur at University of California, San Francisco, a world-
renowned center of biomedical research with almost $700 million in support from the NIH (ranking 3rd among
all institutions). He has the full support of the Division of Pediatric Oncology and the UCSF Cancer Center,
both of which have a long-track record of supporting physician-scientist investigators.

Public health relevance
Project Narrative Gene rearrangements involving receptor tyrosine kinases (RTKs) represent a frequent and diverse set of oncogenic driver alterations across human cancer, and resistance to tyrosine kinase inhibitor (TKI) therapies are inevitable for most patients with advanced cancers and the major cause of mortality. We recently discovered that notable RTK fusion oncoproteins form their own pathogenic subcellular compartment, membraneless cytoplasmic RTK protein granules, to coordinate oncogenic RTK and RAS signaling. This proposal will test therapeutic approaches that exploit the unique signaling properties of this cancer-specific biomolecular condensate.